Cross-disciplinary Training in Immunology, Inflammation and Infectious Disease

Abstract
Interdisciplinary research in Immunology, Inflammation and Infectious Disease affects a wide variety of human
diseases and has been fostered at the University of Utah via a campus-wide research initiative. In connection
with these efforts, the Immunology, Inflammation and Infectious Disease (III) Training Program seeks to bring
together faculty and trainees across the University of Utah Health campus to foster collaborative research in
basic and translational immunology. This application is the recipient of substantial institutional backing and
requests support for 4 pre-doctoral and 2 post-doctoral trainees. The main component of the III Training
Program is individualized research training under the guidance of 30 faculty members in 9 basic and clinical
departments across campus. Pre-doctoral trainees who have completed their qualifying exam are eligible for
up to 2 years of support. Post-doctoral trainees are also eligible for 2 years of support. Both groups are
selected by the Steering Committee from a large and highly competitive pool of candidates based on prior
research excellence, a research proposal and letters of recommendation. It is anticipated that as part of their
normal graduate education, trainees will complete their coursework, participate in seminars and retreats,
present their research in departmental settings, write a thesis proposal, perform thesis research, publish
results and defend their thesis research. In addition, the Training Program will enhance graduate education
through the following activities: 1) a one-month clinical immunology rotation at ARUP, the national pathology
reference laboratory affiliated with the University of Utah; 2) formal training in grant-writing, leading to
submission of an extramural grant proposal; 3) support for travel to present data at scientific meetings; 4)
regular lunchtime discussions of research progress with other Training Program trainees; 5) interaction with
invited seminar speakers; 6) annual presentation of research at the III retreat; 7) guidance in the effective
utilization of pre-doctoral and post-doctoral Individual Development Plans (IDPs); 8) formal mentoring in the
use of biostatistics related to immunological research; and 9) a post-doctoral mentoring committee to provide
individualized career guidance. Given the exceptional training track record of our faculty, available resources
to support research and robust institutional support, the III Training Program will provide an ideal platform to
train the next generation of human disease-focused immunologists.

Public health relevance
Project Relevance to Human Health Immunology is an interdisciplinary science with direct relevance to many human diseases, including infectious diseases, autoimmune diseases, inflammatory diseases, immunodeficiency diseases and cancer. The training of pre-doctoral and post-doctoral researchers will meet a growing challenge to understand and exploit the immune system to treat human disease. The Immunology, Inflammation and Infectious Disease Training Program will guide the development of the next generation of immunology researchers with the appropriate experience and knowledge to meet this challenge.